Role of vascular KATP channels in Alzheimer’s neurodegeneration and dementia

Abstract
A major focus of our efforts is to understand the mechanistic basis and functional consequences of
ATPsensitive potassium (KATP) ion channels in the cardiovascular system. There are contradictory reports of
KATP channel involvement in Alzheimer's Disease (AD) pathogenesis, and we hypothesize that this is
because of the involvement of different channels in neurons versus in cerebral blood vessels. We propose that
blocking KATP channels in blood vessels specifically will be beneficial, and we propose to test this in AD
model mice by precise genetic manipulation of cardiovascular KATP channels. If successful, these studies will
form the background to the testing of relevant pharmacological approaches to CS therapy in animal models
and in humans, with the ultimate goal of developing a specific therapy for CS and related pathologies.

Public health relevance
Project Narrative Alzheimer's Disease is the most common cause of dementia and a leading cause of death in the elderly. Brain function depends on the blood flow that supplies nutrients and oxygen, and deficient control of blood flow in the brain may be important in development of dementia. We are using animal studies to understand how such dysregulation can arise and the consequences for brain function, with the long-term goal to develop new specific therapies for such pathologies.